Targeting HuR to improve a synthetic lethal therapy for pancreatic cancer

Abstract No changes from the parent R01.

Public health relevance
Project Narrative Not applicable. There are no changes from the parent R01.